Transporting Stable RNA Across the Blood-Brain Barrier for On-Demand Translation

PROJECT ABSTRACT
While modern medicine has seen many advances that have improved human health over the last century, most
medications available to the public do not act on the cause of disease, mainly focusing on alleviating symptoms
associated with downstream effects. The overarching goal of my research program is to develop nanoparticles
with pathologically responsive chemistries to enable the targeted delivery of disease-modifying biologic agents.
One such focus is on the use of RNA-based therapies. Compared to traditional methods of altering gene or
protein expression that involve editing or modification, RNA-based therapies offer several advantages, including
a lower risk of off-target genetic mutations, temporary and controlled therapeutic gene expression, and a shorter
production time, which facilitates rapid responses to various emerging health challenges. However, the
translatability of RNA-based therapeutics relies on some sort of delivery vehicle or modification to assist in
biologic transport, like a nanoparticle. Although delivery of nucleic acids in lipid nanoparticles (LNPs) has been
successful, the effect is transient due to the transient nature and RNAse degradability of nucleic acids, which
means multiple injections are often required to receive a lasting protective effect and therapeutic effects are
minimized. Furthermore, LNPs notoriously traffic payloads to the liver, which does not enable their use in
alternative tissue targets. In this proposal, we lay out a high-risk, high-reward approach to 1. Increase the stability
of RNA in vivo, 2. Control the timing of RNA release and protein translation, and 3. Enable the delivery of RNA-
based therapeutics into the brain, therefore addressing the current translational concerns and extending RNA
therapy to tissues that are difficult to reach using polymer-based nanoparticles, called polymersomes (Figure 1).
Furthermore, although our initial focus is on mRNA, our approach could be widely applied to other negatively
charged RNAs. Stimuli-responsive coacervated mRNA will be encapsulated in polymersomes and delivered
across the blood-brain barrier, enabling RNA translation on demand in brain tissue for the first time.

Public health relevance
PROJECT NARRATIVE Modern medicine usually helps with symptoms of disease, but not with causes of disease. RNA-based therapies, like the COVID-19 vaccine, can work on the cause of disease but have some hurdles in translation including their short-lived action and in vivo degradability. We propose a technique to stabilize RNA for long-term use, trigger its release only when needed, and deliver it across the blood-brain barrier to enable RNA as therapy for neurologic conditions.